Maternal Postpartum Symptom Profiles and Associated Social Determinants of Health

ABSTRACT. Annually 3.8 million women give birth in the United States (US). Many postpartum mothers
experience an array of postpartum symptoms, such as sleep disturbance and postpartum depression, which
have been linked to postpartum weight retention and long-term weight gain, increasing the cardiovascular risks
over the life course. Thus, postpartum symptoms and their effects impact mothers’ overall health and quality of
life. Postpartum symptoms often co-occur and are correlated to each other, which is referred to as symptom
clusters. Compared to an individually manifested symptom, symptom clusters are more difficult to manage and
contribute to worse health outcomes. Previous research has focused on either individual symptom severity or
occurrence, which limits our understanding of how postpartum symptom clusters manifest and impact health.
In addition, a lack of racial-ethnic diversity in prior research creates a critical gap in understanding the racial
disparities in US maternal health. This study will use data from a federally-funded study, Community Child
Health Network, and will include 940 Black and 408 Hispanic mothers (76% of the sample). The aims are to:
Aim 1. Identify subgroups of mothers with different symptom profiles at 6 months postpartum using latent
profile analysis. This approach will allow identifying subgroups of mothers who share similar symptom severity
experiences (profile) and those who are at-risk for worse symptom experiences so that personalized
interventions can be developed. Aim 2. Examine individual-, relationship-, and community-level social
determinants of health (SDOH) associated with each symptom profile. This will provide important knowledge
as to which SDOH influence postpartum symptom profiles. Aim 3. Examine the association between allostatic
load and each symptom profile. Allostatic load is a marker of cumulative physiological wear and tear that has a
subsequent impact on cardiovascular and metabolic health (e.g., obesity), which contribute to maternal
mortality and morbidity. Yet, the relationship between allostatic load and postpartum symptom profiles is
unknown. Therefore, examining this relationship will provide novel insights into the health risks of postpartum
mothers that will contribute to new targeted intervention strategies. This study aligns well with the National
Institute of Nursing Research Strategic Plan to promote personalized symptom management and special
interest priority in SDOH. Findings will provide important knowledge that can advance our understanding of
postpartum symptom profiles and SDOH to inform future research. Training: The mentorship team with
substantive and methodological expertise will support the applicant’s training to successfully conduct the study
and prepare for her future steps as a nurse scientist. The following training goals are to gain and expand
knowledge in: (1) complex postpartum symptom experiences and SDOH; (2) advanced quantitative methods
used to characterize postpartum symptom profiles; (3) methods used in symptom science research and
analysis of large data; and (4) intervention development to improve postpartum symptom experiences.

Public health relevance
PROJECT NARRATIVE Mothers commonly experience symptoms such as worse sleep, anxiety, stress, postpartum depression, and posttraumatic stress after birth, all of which can impact their health and well-being. This study will help us to understand the complex symptoms of mothers and what factors contribute to these symptom experiences. The study findings will provide important new information that can be used to develop new ways to reduce these symptoms and improve the health of postpartum mothers.